PHASE II STUDY OF ZIDOVUDINE AND ALPHA 2A INTERFERON IN KAPOSI'S SARCOMA

The objectives of this ACTG study are to evaluate the safety and efficacy of combination therapy with ZDV and recombinant interferon alpha-2a when administered to patients with AIDS-associated Kaposi's sarcoma and to determine the anti-tumor response rate and response duration.